Attacking the Global Problem of Antimicrobial Resistance

Project Summary
Besides the impact on health care, the economic impact of antimicrobial resistance is significant. More than
two million infections a year are caused by bacteria that are resistant to at least first-line antibiotics, costing the
US health care system 20 billion dollars each year. Pseudomonas aeruginosa (PA) causes over 51,000 health
care associated infections per year in the US, of which 13% are multi-drug resistant (MDR). Non-antibiotic
approaches to prevent and treat bacterial infections provide attractive alternatives/adjuncts to antibiotics no
longer effective against MDR PA isolates. One of these, glycyrrhizin (GLY), an extract from the licorice root
(Glycyrrhiza glabra), is effective in treatment of animal models of sepsis, colitis, lung and brain injury; and is
used in the clinical management of chronic hepatitis. After infection, GLY reduces extracellularly released high
mobility group box 1 (HMGB1), a prototypic alarmin that activates cell surface innate immune receptors
affecting host inflammatory responses. GLY has direct antimicrobial effects in PA experimental keratitis
induced by non-MDR clinical (keratitis) isolates (e.g., KEI 1025) and by MDR9, a non-ocular isolate.
Preliminary/recently published data support that in MDR9 induced PA keratitis, GLY: a) permeabilizes bacterial
membranes, b) reduces efflux pump activity, increases bacterial killing and d) combined with Ciprofloxacin in
vivo, reduces the neutrophil infiltrate and plate count optimally. Therefore, our overarching hypothesis is that
GLY is non-toxic to the cornea and ocular adnexa and after PA infection, binds to HMGB1 preventing
activation of innate immune receptors. To test this hypothesis two Specific aims are proposed.
Specific Aim 1: Tests the hypothesis that GLY is well-tolerated and does not alter the cytoarchitectue nor the
physiological parameters of the normal cornea, conjunctiva and ocular adnexa. In this aim, we will test the
effects of GLY given topically on the uninfected, normal cornea, and if intraocular pressure (IOP), tear volume,
corneal nerve pattern, corneal sensitivity, resident immune cells and/or conjunctiva are altered.
Specific Aim 2: Tests the hypothesis that GLY's protective effect on PA keratitis is mediated by inhibiting
HMGB1 amplification of TLR4/RAGE signaling pathways in myeloid cells. This aim will test if GLY binding to
HMGB1, inhibits HMGB1-TLR4 (-RAGE) interactions and signaling pathways, with downstream effects on
immature myeloid dendritic cell (DC) maturation, macrophage production of proinflammatory cytokines and
chemokines and neutrophil infiltration and function. Aim 2a will test this hypothesis in GLY treated mice after
infection with KEI1025, a non-MDR PA keratitis isolate using TLR4 and RAGE KO mice and myeloid specific
HMGB1 KO mice. Aim 2b is translational and will test this hypothesis in mice in which GLY treatment is
combined with Moxifloxacin and initiated 18h after infection with MDR PA.

Public health relevance
Project Narrative Pseudomonas aeruginosa (PA)-induced keratitis is a common causative organism of contact lens-related disease in developed countries, in ocular trauma/accidents in less developed ones and of global concern regarding emerging antibiotic resistance. Our overarching hypothesis is that GLY is non-toxic to the cornea and ocular adnexa and after PA infection, binds to HMGB1, inhibits HMGB1-TLR4/RAGE signaling, affects immature myeloid DC maturation, macrophage production of proinflammatory cytokines and neutrophil infiltration and function to lessen disease; and when combined with antibiotics no longer effective against multi drug resistant isolates, potentiates antibiotic effectiveness.